Targeting the Unfolded Protein Response Master Regulator BiP to Induce CellDeath in Multiple Myeloma

PROJECT ABSTRACT
This application describes my research on a plasma cell (PC) survival pathway in Multiple Myeloma (MM) to be
performed within the context of a 5-year mentored career development plan. My ultimate goal is to become an
independent physician-scientist in the area of MM as a laboratory-based Hematology/Oncology academic and
to develop potential therapeutics for use in trials. Under the guidance of my primary mentors, Dr. David Allman
and Dr. Alfred Garfall, at the University of Pennsylvania, I have developed a structured training plan consisting
of intensive laboratory research, didactics, and oversight by an experienced faculty advisory committee. The
proposed research will center on mechanisms of cell survival in MM mediated by the unfolded protein response
(UPR) pathway by focusing on a key negative regulator of the pathway, BiP, and its potential as a therapeutic
target. MM is an incurable plasma cell cancer that despite treatments is universally fatal. One key reason for lack
of durable therapies is a limited understanding of survival pathways, such as the UPR. Professional protein
secreting cells such as PCs are uniquely dependent on the UPR for survival. PCs produce 2-10,000 antibodies
per second, and this extreme protein load actively engages the UPR to adapt to the stresses of high output
protein production. If stress is unable to be resolved, the UPR transitions from pro-survival to pro-death. It is
known that this transition occurs through gene transcription programs, but the specific programs and their time
courses are unclear. I require further training in bioinformatic analysis of transcriptional datasets to tease apart
this transition. The activation of these gene programs by the UPR is controlled by the negative regulator BiP. Its
removal leads to UPR activation, making it both a good target to study the pro-survival to pro-death transition
but also as a therapeutic target to force prolonged UPR activation and death. By using a novel BiP-targeting
agent and novel MM model systems, this proposal will characterize changes in gene expression during the UPR-
mediated pro-survival to pro-death transition and determine what death pathways are responsible for this
transition (Aim1). It will also test the efficacy of novel BiP-targeting approaches in untreated and relapsed MM in
a patient derived xenograft mouse model (Aim2). These findings will provide insight into the biology of MM
survival mechanisms, provide the rationale for BiP-targeting as a therapeutic approach and provide data for
larger grant applications. In undertaking the proposed studies and training plan, I will develop the skills and
expertise necessary to establish an independent career in translational research.

Public health relevance
PROJECTIVE NARRATIVE BiP is a protein that regulates the unfolded protein response, a survival pathway important for the cancer multiple myeloma (MM). I have found that removing BiP in MM causes cancer death. I will investigate how this cancer death occurs and if this is a workable treatment strategy in MM.